Animal Food Regulatory Program Standards (AFRPS)

The West Virginia Department of Agricultural – Regulatory and Environmental
Affairs Division (WVDA-READ) is comprised of four sections; Food and Agricultural
Materials, Laboratory, Pesticide Regulatory and the Environmental Section.
Our specific aim for this grant opportunity is to help support the efforts of the
WVDA-READ in fulfilling its mission statement of protecting the health, property and
environment of the citizens of West Virginia, through legislative mandates, by providing
uniform and equitable inspection, sampling, investigative services and analytical
analysis to industries and the farm communities.
The agency has in place the WV Commercial Feed Law and Rule which we
adopt Federal Regulations in their entirety. Further research would be necessary to
evaluate the legal authority and regulatory provisions that correspond to the sections of
the FDA&C and the Federal Regulations in Standard 2 of the AFRPS.
WVDA-READ is seeking ISO/IEC 17025:2005 accreditation for four methods in
the agricultural materials section through this grant. Accreditation will enhance the
laboratory in being recognized as an officially competent feed testing laboratory with
technical results being defensible to the ISO/IEC 17025:2005 standard.
WVDA-READ will identify gaps in the existing programs and begin rewriting
laboratory and regulatory standard operating procedures, establish a method review
schedule, begin management reviews and establish training needs in accordance with
this grant.

Public health relevance
The West Virginia Department of Agriculture, Regulatory and Environmental Affairs Division (WVDA-READ) is seeking ISO/IEC 17025:2005 accreditation for four methods in the agricultural materials laboratory. Accreditation will enhance the laboratory in being recognized as an officially competent feed testing laboratory with technical results being defensible to the ISO/IEC 17025:2005 standard. The WVDA will be capable of aiding the FDA in analytical capacity for surveillance assignments, foodborne outbreak testing attributed to feed safety, and surge capacity for large-scale feed emergencies. The support received from this grant will assist in the continued efforts in the Regulatory Programs to ensure that safe and quality feed products are available to the citizens of West Virginia and the nation by assuring uniformity of feed regulatory programs in the United States.